Mitochondria-cytoplasm interactions for cytosolic Fe-S cluster assembly

Abstract
In eukaryotes, the biosynthesis of essential Fe-S cluster cofactors is compartmentalized with a mitochondrial
iron-sulfur cluster (ISC) machinery and a cytosolic iron-sulfur protein assembly (CIA) machinery. We found that
isolated cytosol by itself cannot synthesize Fe-S clusters. Addition of mitochondria to the cytosol, however, allows
this process to proceed. Similarly, thiolation of tRNAs is critical for accurate protein synthesis, and isolated
cytosol alone cannot thiolate tRNAs but will do so upon addition of mitochondria. We found that the ISC
machinery in mitochondria generates two distinct intermediates, Sint and (Fe-S)int. These intermediates are
exported to the cytosol by the Atm1 transporter in the mitochondrial inner membrane. Once exported, Sint is
utilized for tRNA thiolation and (Fe-S)int is utilized by the CIA machinery for cytosolic Fe-S cluster assembly.
Aim 1 is to delineate the pathways for synthesis of Sint vs. (Fe-S)int. The site will be ascertained at which the
pathway for Sint formation bifurcates from the ISC pathway for mitochondrial Fe-S cluster synthesis. The site at
which (Fe-S)int formation bifurcates will likewise be determined. Mitochondria will be isolated from S. cerevisiae
strains lacking components of the ISC machinery and they will be tested in mitochondria-cytosol mixing assays.
Aim 2 is to demonstrate a direct role for Atm1 in exporting both Sint and (Fe-S)int. We will determine if the
intermediates accumulate in Atm1-depleted mitochondria and if newly imported Atm1 into these mitochondria
can restore the export process. Atm1 will be overexpressed to ascertain if this alters competition of Sint and (Fe-
S)int for export. The exported and active (Fe-S)int, but not Sint, may contain bound GSH and this will be tested.
Aim 3 is to define initial interactor(s) of (Fe-S)int in the cytosol. We will determine whether the glutaredoxins
Grx3/4 and/or the Cfd1/Nbp35 scaffold complex interact with purified (Fe-S)int to build their own Fe-S clusters.
Aim 4 is to purify and characterize Sint and (Fe-S)int exported from mitochondria. Exported intermediates will
be purified by size exclusion chromatography, and active fractions will be characterized by ICP-MS, ESI-MS,
and other spectroscopic studies with an aim to identifying the chemical composition of the intermediates.
Aim 5 is to define whether mitochondria isolated from mammalian cell lines (CAD or HEK293) also produce
and export two distinct intermediates, Sint and (Fe-S)int, and whether they can be swapped for the yeast
equivalents in functional assays. Mitochondria lacking ABCB7 (human Atm1) will be tested for their
ability/inability to generate Sint and (Fe-S)int intermediates and to export them for cytosolic use.
The significance of this work derives from the critical nature of the processes that lie downstream of the
exported intermediates. Impaired thiolation of cytosolic tRNAs (downstream of Sint) leads to disruption of protein
synthesis. Impaired cytosolic Fe-S cluster assembly (downstream of (Fe-S)int) may create a cellular catastrophe
due to genomic instability. Understanding the mechanistic details of mitochondrial production and export of Sint
and (Fe-S)int along with detection/identification of these exported species as proposed here is highly significant.

Public health relevance
Project Narrative Iron-sulfur (Fe-S) clusters are critical protein cofactors required for essential cellular processes such as ribosome biogenesis, and thiolated tRNAs are needed for efficient protein synthesis. We found that isolated cytoplasm alone cannot synthesize Fe-S clusters or thiolate tRNAs but can do so upon addition of mitochondria. Here we propose to delineate mitochondrial contributions to these cytoplasmic processes; the results may identify a vital mitochondria-cytoplasm interaction required for cell survival.